COMPARISON OF DIFFUSE OPTICAL TOMOGRAPHY AND POSITRON EMISSION TOMOGRAPHY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Aim of this subproject is to determine the feasibility of comparision of breast images obtained with DOT and PET.